GENE TRANSFER FOR THERAPY OF IL 2 RECEPTOR GAMMA CHAIN DEFICIENT X LINKED SCID

The gamma chain gene of the IL-2 receptor (IL2RG) has been identified as responsible for X-linked severe combined immunodeficiency (SCID), the most common form of human SCID. The only available lifesaving treatment at the present time is bone marrow transplantation, but drawbacks of this procedure include the lack of HLA matched donors in over 2/3 of cases, poor post-transplant B cell function, and late T cell loss. In vivo negative selection against cells expressing a mutant IL2RG makes X-linked SCID a promising candidate for therapy with retrovirally transduced autologous repopulating stem cells. This strategy was pursued by comparing different retrovirus constructs for titer, gamma chain expression in transduced cell lines, correction of the functional defect in EBV-B cell lines from SCID-affected patients with defined IL2RG defects, and monitoring the development of cord blood stem cells transduced with IL2RG retroviruses in SCID mice. These experiments have shown significant cell surface expression of the gamma chain protein in previously deficient cell lines from SCID patients. The availability of a large panel of patient cell lines will permit evaluation of potential dominant negative mutations. SCID patients prenatally diagnosed with defined IL2RG mutations have had their cord blood collected at birth for experimental transduction and evaluation of lymphocytogenesis. Canine spontaneous gamma chain mutations resulting in SCID dogs are being studied in collaboration with Paula Henthorn, at the U. of PA School of Vet. Med. Marking experiments in normal dogs pretreated with cytokines and sublethal irradiation have achieved unprecidented levels of long-term expression of human gamma chain for over one year. Follow-up experiments in SCID dogs are planned.